Paraventricular Nucleus of the Thalamus and Nucleus Accumbens Neurons in Aversion-Resistant Alcohol Drinking

Project Summary/Abstract
This project proposes to investigate the underlying neural mechanisms within the nucleus accumbens (NAc)
driving cue-elicited reward seeking during aversion-resistant alcohol drinking (ARD), defined as drinking
despite negative consequences or “compulsive alcohol drinking”, using optogenetics and simultaneous in-vivo
electrophysiology and optogenetics in male and female Long-Evans rats. Environmental reward predicting
cues provide a source of motivation for reward-seeking which may be heightened following extended alcohol
use, resulting in maladaptive, ARD, a defining feature of alcohol use disorder (AUD). Despite the well-
established role of the NAc in mediating cue-elicited reward seeking, motivation, and ARD, the neural signature
within the NAc during cue and alcohol access in ARD is not known, which greatly limits prevention and
treatment of AUD. The NAc is innervated by glutamatergic projections from the paraventricular nucleus of the
thalamus (PVT). This projection is thought to be relevant for processing motivational conflict and preventing
unproductive reward seeking, while sparing normal affective behavior. However, the PVT-to-NAc pathway’s
role in modulating NAc encoding during ARD or how the activity of PVT-to-NAc neurons alter ARD is not
known. Thus, the central hypotheses of this project are 1) the NAc encodes cue and outcome information
related to ARD. Specifically, neural activity in the NAc responds to reward (alcohol access) predictive cues and
to alcohol rewards in a discriminative stimulus task and that over continued alcohol use, this activity increases
in correlation with the development of ARD and 2) the neuronal activity in the NAc is causally related to an
excitatory projection from the PVT that acts to prevent ARD initially, but erodes over time resulting in ARD. This
project will assess the neural mechanisms of cue-elicited reward seeking and ARD during a discriminative
stimulus task using both optogenetic circuit manipulations and simultaneous optogenetics and awake-and-
behaving electrophysiology recordings. The training plan for this project is curated in an ideal research
environment in the Department of Neuroscience at the University of Minnesota which will provide training in
cutting edge neuroscience techniques, professional development, and research ethics that will amass an ideal
training experience to facilitate my career as an independent alcohol research scientist. The specific research
hypotheses are 1) Optogenetic inhibition of PVT-to-NAc neurons at cue presentation and alcohol reward will
cause ARD in otherwise aversion-sensitive rats. 2) Optogenetic excitation of PVT-to-NAc at cue presentation
and alcohol reward will reduce ARD, causing aversion-sensitivity, in otherwise ARD rats. 3) Ensembles of
neurons within the NAc encode cue and alcohol rewards during ARD. This encoding is facilitated by the PVT-
to-NAc projection whereby PVT-to-NAc inhibition will increase NAc encoding of cues and alcohol rewards and
PVT-to-NAc excitation will reduce this encoding within the NAc. Completion of the proposed work will elucidate
understanding of the neural mechanisms of ARD and will aid in the prevention and treatment of AUD.

Public health relevance
Project Narrative Aversion-resistant alcohol drinking (ARD), defined as drinking alcohol despite known negative consequences, is a defining and debilitating feature of Alcohol Use Disorder (AUD) in which the neural mechanism is yet to be determined, resulting in difficulty in the development of prevention and treatment for AUD. The research focus of this proposal is to measure and manipulate thalamo-striatal neural circuitry during the development of ARD by 1) bidirectionally manipulating paraventricular nucleus of the thalamus (PVT)-to-nucleus accumbens (NAc) neurons in a discriminative stimulus task and 2) recording neurons in the NAc in-vivo while simultaneously optogenetically inhibiting PVT-to-NAc neurons. Completion of this project will improve our understanding of the neural mechanisms of ARD and will provide foundational training in cutting edge research techniques, professional development, and research ethics that will prepare me for a career as an independent addiction research scientist.